Tools for measuring post-translational modification enzyme activity in vitro and in cells

Project Summary/Abstract
My laboratory works at the interface of chemistry and biology on technology development for
post-translational modification enzyme activity measurement. We use a broad variety of
techniques including peptide chemical biology, spectroscopy, proteomics, cell biology, and
analytical chemistry to create tools that help answer biological questions with molecular
precision. We have spent the most time on studying and building a toolkit for measuring kinase
activity, both in vitro and in live cells. We are currently working on building out our platform
technology called KINATEST-ID to characterize kinase preferences, design novel substrates,
and apply them in kinase assays with innovative read-outs. Our goals for the next five years are
(1) to build up our understanding of kinase-substrate interactions using multiple avenues: in vitro
phosphoproteomics experiments to characterize the substrate profiles of many different kinases,
comparing substrate preference motifs to try to dissect differences, designing novel artificial
substrate tools that could distinguish between the activities of different kinases, and using
cutting-edge artificial intelligence-based structure-based computational methods like Rosetta
and AlphaFold to characterize and predict determinants of substrate selectivity; and (2) to
develop and implement assay read-out detection methods that can meet different levels of
technical needs for drug screening, drug target validation, pharmacodynamic monitoring for
companion diagnostics, as well as basic study of fundamental questions about enzyme function
and interaction with substrates in cells.

Public health relevance
Project Narrative My laboratory works at the interface of chemistry and biology on technology development for post-translational modification enzyme activity measurement. We are currently working on building out our platform technology called KINATEST-ID to characterize kinase preferences, design novel substrates, and apply them in kinase assays with innovative read-outs. Our goals for the next five years are to build up our understanding of kinase-substrate interactions and develop and implement detection methods to use for inhibitor screening and answer fundamental questions about enzyme function and interaction with substrates.